Core C - Bone Core

CORE C: Bone Core Abstract
The Bone Core of the Program Project will provide shared facilities and services for procuring,
processing and interpretation of tissues from both clinical samples and animal models utilized in
all projects of the program. This will be achieved through the following aims:
Aim 1. Experimental design/consultation. This include methods regarding endpoint
analyses and abilities and limitations of methods.
Aim 2. Pathological interpretation. For histologic specimens, histopathology and
scoring of immunohistochemistry.
Aim 3. Processing of tissues. Both osseous tissues and pooling resources for soft
tissue processing. This includes fixation, decalcification, paraffin embedding and sectioning of
decalcified sections and fixation, plastic embedding and sectioning of undecalcified sections.
Aim 4. Routine and special stains for mineralized tissues. This includes for
mineralized tissues, osteoclasts and immunohistochemistry.
Aim 5. Histomorphometric analysis of both osseous sections and tumor tissue.
This includes measurement of specific bone-related structural and cellular parameters.
Aim 6. Procurement of clinical tissue samples. Bone marrow samples for
disseminated tumor cells isolation and blood for circulating tumor cells and serum as needed.
Core support of these services will promote efficiency of specimen analysis and facilitate
interactions between projects through the similar model systems and their common analyses. A
significant benefit to the program as a group will be a standardized format for analysis of
specimens from the common animal models that will be using different experimental
approaches/targets. This will provide valuable information that can be shared and compared
across the projects in the program. To accomplish these goals, the core is directed by Dr.
Kenneth Kozloff, who is an expert in bone biology. In addition, the core is supported by Dr.
Rohit Mehra, a board-certified urologic oncology pathologist and Dr. Todd Morgan, a urologist
and physician scientist with expertise in disseminated tumor cell procurement and biology.
Additional expertise in bone histomorphometry is provided by our consultant Dr. Tom Wronski a
nationally recognized expert in this field and in bone pathology by Dr. David Lucas, an anatomic
pathologist who specializes in bone. Overall this core will continue to provide comprehensive
and unique services that are required by all the projects of this Program.

Public health relevance
Project Narrative The Bone Core of the Program Project will provide shared facilities and services for processing and interpretation of tissues from the animal models utilized in all projects of the program. The overall goal of the core facility is to provide centralized histologic and image analysis support for investigators in the project. Such a standardized format with provide valuable information and consistency across the projects in the program.